Building Hybrid Operations to Promote Equity (HOPE) and improve clinical trial access across North Carolina

ABSTRACT
The landscape of clinical research is in a constant state of evolution as a greater understanding of unmet patient
needs and current clinical trial limitations are exposed, necessitating innovative solutions to address the
challenges encountered by traditional clinical trial paradigms. One of the most pressing issues is the difficulty in
recruiting and retaining diverse patient populations, leading to significant underrepresentation of minority groups,
rural communities, elderly patients, and individuals with limited access to healthcare resources. This lack in
diversity not only skews our understanding of treatment efficacy and safety but also compromises the
generalizability of data generated from traditional trials. In response to these challenges, hybrid decentralized
clinical trials (DCTs) have emerged as a promising alternative. Hybrid DCTs allow for tasks aligned with clinical
practice to be performed by local health care providers (HCPs) with their established patient relationships and
limit clinical trial site visits to those with complex procedures that require extensive knowledge of the
investigational product. By leveraging the capabilities of both local HCPs and academic medical centers,
implementing digital health tools, and minimizing the need for frequent in-person visits, hybrid DCTs prioritize
patient comfort and convenience while breaking down geographic and socioeconomic barriers. Here we outline
a comprehensive plan to establish the Hybrid Operations to Promote Equity (HOPE) at the University of North
Carolina- Chapel Hill Lineberger Comprehensive Cancer Center (LCCC). This proposal will address the health
disparities within North Carolina’s diverse patient population where nearly 30% of individuals identify as
belonging to a minority race across vast rural and urban regions. By engaging local healthcare providers in bi-
directional educational efforts and creating use-friendly tools, we aim to facilitate patient referrals and education
on clinical trial opportunities, particularly in underserved communities. Additionally, our approach includes the
development of specialized infrastructure and oversight procedures to streamline internal hybrid DCT
development and optimize clinical and regulatory procedures. Success of these endeavors will create a HOPE
network of healthcare providers across the state of NC with access to clinical trial opportunities for their patients
with most/all assessments occurring locally and will develop HOPE infrastructure to pilot hybrid DCT efforts to
expand awareness of and participation in clinical trials addressing disparities in cancer prevention, treatment,
and control across NC.

Public health relevance
PROJECT NARRATIVE Development of Hybrid Operations to Promote Equity (HOPE) will address clinical trial disparities in North Carolina’s diverse patient population by creating an infrastructure for hybrid decentralized trials (DCTs) and building a network of engaged physicians to refer patients to such opportunities. These efforts are focused on increasing clinical trial access to underserved communities by reducing geographic enrollment barriers and using culturally competent local health care providers. The aims of this proposal will promote equity in clinical trials and improve outcomes for all patients, regardless of their age, race, ethnicity, gender, background, or geographic location.